Defining the fungal-host interactions between the pathogenic yeast Cryptococcus neoformans and human microglia

PROJECT SUMMARY
Cryptococcus neoformans, the etiological agent of cryptococcal meningitis (CM), is a globally distributed
environmental yeast that mainly causes infections in immunocompromised individuals. Particularly in low-
resource countries, the mortality rate of CM can reach 81% and accounts for 19% of HIV/AIDS-related deaths
each year. Despite this high burden, CM treatment options are suboptimal, largely due to an incomplete
understanding of the fungal biology and host-pathogen interactions. In immunocompromised individuals, once
inhaled, C. neoformans escapes from the lungs and disseminates with special predilection for the central nervous
system (CNS). Once in the brain, C. neoformans interacts with microglia, the tissue-resident macrophages of
the CNS. Previous studies indirectly showed that microglia are ineffective at controlling this fungal infection. It
has also been shown that many phagocytosed yeasts can survive, replicate, and avoid killing in the microglial
phagosome, and this can be influenced by prior yeast opsonization. The mechanisms underlying this fungal
survival and proliferation within the CNS, however, remain unclear. My preliminary studies have expanded on
these previous findings, showing that immortalized and primary human microglia have decreased phagocytic
and killing activity that is specific to C. neoformans. This has led to my central hypothesis that C. neoformans
survives in the CNS by using both novel, capsule-independent, antiphagocytic mechanisms and phagosome
maturation disruption within microglia, and that these mechanisms vary based on yeast opsonization. To test
this, I will use an immortalized human microglia cell line to study the interactions between these immune cells
and C. neoformans. This model is advantageous as it is more translational that rodent-derived cell lines, and it
is easier to culture and obtain than primary human microglia. Experiments in Aim #1 will define the process of
phagosome maturation in microglia after engulfment of wild-type C. neoformans. I will look at phagosome
development, acidification, damage, and subsequent function. Experiments in Aim #2 will identify antiphagocytic
cryptococcal proteins and determine their impact on microglia killing efficiency and phagosome maturation.
Experiments in Aim #3 will define if yeast opsonization leads to differential receptor engagement and how this
impacts the outcome of the infection. Specifically, I will study how opsonization impacts microglial phagosome
maturation and killing efficiency, as well as study the receptors necessary for cryptococcal recognition and
engulfment. Overall, my project takes advantage of the expertise in cryptococcal-phagocyte interactions and glia
biology and function of my sponsor and co-sponsor laboratories, respectively, and will yield a better
understanding of the interactions between C. neoformans and microglia, ultimately contributing to the knowledge
of fungal biology and CM pathogenesis, making it more likely that effective therapeutics to treat CM will be
developed.

Public health relevance
PROJECT NARRATIVE Cryptococcal Meningitis (CM), caused by the fungal pathogen Cryptococcus neoformans, is a disease with severe global health burden, as it is responsible for 19% of HIV/AIDS-related death and has a mortality rate as high as 81%. Although the pathogen is acquired by inhalation, the fatal pathology occurs in the brain, and microglia, the immune cells of the brain, are not able to control the cryptococcal infection due to unknown mechanisms. This work will define the interactions between microglia and C. neoformans before and after engulfment, specifically how microglia recognize and engulf the fungus, as well as interact with the fungus after internalization, providing fundamental knowledge that can be leveraged for the development of more effective diagnostics and treatments for CM.